A Universal Platform for Ultrahigh-Throughput Biocatalyst Evolution With micro-Mass Spectrometry

Abstract
The advancement of biotechnology relies on the ability to rapidly screen and optimize genetically engineered
enzymes and pathways. While significant innovations have occurred in computational methods and gene
synthesis, screening technologies have stagnated, with traditional microwell plates—developed nearly 60 years
ago—still dominating the field. Fluid Discovery aims to disrupt this space with a novel screening platform based
on precision nanoliter fluid handling, enabling screens at 100 times the scale of current methods while
significantly reducing costs. This transformative approach combines scalable hardware, label-free mass
spectrometry, and advanced computational techniques to uncover unanticipated enzyme activities and
improvements. Founded by the inventor of these key technologies, Fluid Discovery is uniquely positioned to
drive innovation and commercial success. This grant will support the development of commercial prototype for
early access customers, demonstrating the technology's utility, industrial relevance, and market readiness—key
milestones for securing private funding for commercial scale-up. The team comprises experts in pharmaceutical
development (Dr. Prince), complex instrumentation development and commercialization (Dr. Kiani), and micro
mass spectrometry (Dr. Abate). Together, they bring a proven track record of building successful companies
valued at over $1 billion. Fluid Discovery’s platform will make high-throughput engineering campaigns practical
and affordable for biotech startups and academic labs, while offering efficiencies that appeal to Big Pharma,
transforming the landscape of enzyme and pathway optimization.

Public health relevance
Narrative The objective of this grant is to fuel the development of an innovative nanoliter screening technology. This platform will increase, by orders of magnitude, the scale of screens that can be performed to enable efficient directed evolution of novel biocatalysts.